Administrative Core

PROJECT SUMMARY
The Administrative (Admin) Core is responsible for overall governance, management, and planning for the Texas
Medical Center-Genomic Center for Infectious Disease (TMC-GCID). Final responsibility for all TMC-GCID
administrative and financial activities rests with the contact PI, Dr. Joseph Petrosino, and co-PIs, Drs. Richard
Gibbs, Mary Estes, and Anthony Maresso. This Multi-PI (MPI) team will provide overall direction to the scientific
and administrative operations of the TMC-GCID and will participate in meetings as specified in the RFA. The
Program Manager (Dr. Sara Javornik Cregeen) will facilitate daily operation of the Admin Core. She reports to
the TMC-GCID Senior Administrator (Ms. Edith Hu). Together, the Admin Core leadership will achieve the
responsibilities described in this Core proposal, which we have refined during the first 4 years of this program.
The responsibilities of the TMC-GCID Admin Core are to:
• Establish and monitor Project and Core progress timelines as described in each section of the proposal.
• Organize and/or support enhancement activities, such as integration into relevant seminar series,
invite/organize external seminar speakers.
• Hold weekly TMC-GCID internal meetings (described below) to monitor progress and foster synergy.
• Coordinate outreach activities (starting in year one) to enable GCID technologies, data, and results to be
disseminated throughout the local and international research community, as appropriate.
• Engage the robust intellectual property (IP) mechanisms that lie within Baylor College of Medicine (BCM)
Ventures (BCMV, led by BCM Chief Scientific Innovation Officer, Dr. Joseph Petrosino, contact PI) and
ensure that all TMC-GCID members are aware of the processes to disclose potential IP.
• Assist in the organization of the Steering Committee as appropriate and requested by NIAID leadership.
• Organize and engage the TMC-GCID External Advisory Board (EAB).
• Develop, design, implement and monitor cross-GCID Collaborative Pilot Projects.
• Arrange travel for/host GCID annual meeting.
• Establish and manage communication with other GCID and NIAID staff for collaboration and coordination.